Columbus NCORP RFA-CA-18-016

Since its founding in 1983, the Columbus CCOP, now known as the Columbus NCORP, has
been dedicated to providing high quality cancer care options in Central and Southeast Ohio as
well as advancing cancer research through cancer research trials. The Columbus NCORP has
grown in that time to encompass 20 affiliates and sub-affiliates, with 100 doctors serving as
investigators. The NCORP serves a wide variety of populations, from urban areas to rural
Appalachia. Over the six years comprising the next grant period, the NCORP plans to continue
to grow in that capacity, improving its ability to participate in, assist with the design of, and
successfully implement a wide range of cancer research trials, including treatment, cancer
control, screening/surveillance, side effect prevention/management, and cancer care delivery
research studies. In all areas the NCORP has been successful and plans to continue to grow in
its ability to investigate health disparities in its region and increase participation in cancer
research by underserved communities including minority populations, rural communities and
those in Appalachian areas. Cancer care delivery research has been and continues to be a key
component of this goal, as is continuing to improve care practices throughout the consortium.
Close collaboration between NCORP affiliate institutions, non-oncology specialists, primary
care physicians and community organizations is key to this goal. The Columbus NCORP plans
to continue to pursue the cutting edge of cancer research through targeted and genomic
therapies, while simultaneously seeking out and implementing trials that are directly applicable
to those cancers with the highest incidence rate in our region: breast, colon and lung cancers.
Over the past five years as an NCORP, and over the preceding 30 years as the Columbus CCOP,
these areas have been a high priority and will continue to be as we aggressively pursue
treatments that will advance the science of cancer care and best serve our local communities.
The unique challenges facing Central and Southeast Ohio in these areas position the Columbus
NCORP to make real and lasting contributions to cancer research, and the lessons learned here
are widely applicable to regions across the country.

Public health relevance
The Columbus Community Clinical Oncology Program has been serving Central Ohio for 35 years and has been participating in the NCI Community Oncology Research Program since its inception. During that time, the Columbus CCOP has excelled in delivering cancer care and access to clinical studies to a wide variety of populations – from major urban areas to rural Appalachia. The Columbus CCOP is firmly committed to the idea that cancer therapy and clinical trials are mutually supportive, and looks forward to continuing to work and grow as an NCORP community site.